Regulatory Signaling in Repair of Environmentally Induced DNA Damage

DESCRIPTION (provided by applicant): Exposure to ubiquitous environmental carcinogens, such as poly aromatic hydrocarbons and UV light, is cause of human disease. It is well accepted that genetic mutations are an important step in the development of cancer. It has become clear that such mutations are introduced in part by error-prone DNA polymerases. In response to many environmental genotoxins, eukaryotic cells have evolved alternative methods of replicating damaged DNA, via the Trans-lesion synthesis (TLS) Polymerases, consisting of DNA Pol h, Pol k, Pol i, and Rev1. The TLS polymerases are recruited to stalled replication forks, where they mediate replication past damaged DNA. TLS is a central mechanism of replicating DNA that has been modified by exposure to environmental carcinogens, but the TLS is an inherently error-prone process. In addition, aberrant utilization of the TLS polymerases greatly predisposes to mutagenesis. Proper regulation and function of the TLS polymerases is thus a crucial mechanism of protecting genomic integrity. This research will study the mechanisms that regulate recruitment of TLS polymerases to sites of DNA damage in response to environmental genotoxins. In particular, we will test the hypothesis that Cdc7-mediated phosphorylation of Rad18 promotes formation of Rad18-Polh complexes and facilitates bypass of solar UV-induced DNA lesions. In addition, we will determine the mechanisms by which Rad18 ensures selection of the appropriate TLS polymerase in response to UV-induced (Polh) or BPDE- induced (PolK) DNA damage. These experiments will determine the significance of interactions between the TLS polymerases, Rad18, and Cdc7 and will help elucidate the mechanisms responsible for regulating TLS polymerases. Results of our studies will provide a novel link between normal and damage-induced replication and will help explain how environmental genotoxins contribute to mutagenesis.

Public health relevance
Project Narrative. Exposure to environmental carcinogens poses a serious public health risk by compromising the integrity of cellular DNA. DNA damage causes gentic mutations and predisposes to a number of human diseases. This research will shed light into the cellular processes that mediate repair of environmentally induced DNA damage, thus aiding in the development of new strategies to prevent and to treat human disease resulting from damage to DNA. __SpecificAimsTextDelimiter__ 2. Specific Aims The proposed research will elucidate the mechanisms of mutagenesis caused by ubiquitous environmental pollutants, namely solar ultraviolet (UV) radiation and polycyclic aryl hydrocarbons (PAHs). It is well accepted that mutations drive the development of cancer. In the past decade, it has become clear that such mutations are introduced by error-prone DNA polymerases. The main replicative polymerase in mammalian cells, DNA polymerase delta (Polδ), replicates undamaged DNA with high fidelity (~1 error per 105 bases copied). However, it is unable to bypass certain types of damaged DNA, such as cyclobutane pyrimidine dimers (CPDs) or guanosine bulky adducts (dGs), induced by exposure to UV radiation or the PAH Benzo[a]pyrene Di-hydrodiol Epoxide (BPDE, a metabolite of the environmental genotoxin Benzo[a]pyrene). Thus, replication forks (RFs) stall when Polδ encounters these bulky adducts, and DNA replication is interrupted. Because of the threat to genomic stability posed by incomplete DNA synthesis, eukaryotic cells have evolved multiple methods of tolerating and bypassing these fork-stalling DNA lesions. Trans-Lesion Synthesis (TLS) is a major mechanism by which cells tolerate the presence of bulky DNA adducts. Specialized TLS DNA Polymerases (the Y-family DNA Polymerases Polη, Polκ, Polι, and Rev1) have large flexible active sites capable of accommodating helix-distorting bulky lesions and are able to perform replicative bypass of various DNA adducts, thereby preserving the RF. However, Y polymerases perform DNA synthesis in a highly error-prone manner that leads to increased mutagenesis. Different Y polymerases exhibit specificity for bypass of various lesions. For example, Polη bypasses CPD adducts with relative accuracy, while bypass of BPDE adducts by Polη is highly-error prone. Conversely, Polκ accurately bypasses BPDE-adducted dG but not CPD. Appropriate lesion-specific recruitment of TLS polymerases is therefore essential for preventing error-prone lesion bypass, mutations, and cancer, but the precise mechanisms used to ensure selection and recruitment of TLS polymerases are poorly understood. Recruitment of Polη to stalled RFs is dependent on its binding partner Rad18, a molecular chaperone with E3 ubiquitin ligase activity. We have discovered that Rad18 is phosphorylation by the S-phase kinase Cdc7 in the Polη-binding domain of Rad18. We hypothesize that Rad18 phosphorylation provides a mechanism for regulating selection and recruitment of Polη and other Y polymerases to stalled RFs following exposure to environmental genotoxins. Specific Aim 1 will test the hypothesis that Cdc7-mediated phosphorylation of Rad18 promotes formation of Rad18-Polη complexes, thus facilitating bypass of solar UV-induced DNA lesions. Specific Aim 2 will determine the mechanisms by which Rad18 ensures selection of the appropriate Y polymerase in response to UV-(Polη) or BPDE-induced (Polκ) DNA damage. These experiments will determine the significance of interplay between the Y Pols, Rad18, and Cdc7 and will help elucidate the mechanisms that regulate TLS. Results of our studies will provide a novel link between normal and damage-induced replication and will help explain how environmental genotoxins cause mutagenesis. 1. To test the hypothesis that Cdc7-mediated phosphorylation of Rad18 facilitates bypass of solar UV-induced DNA lesions. 1.1 Does Cdc7-mediated phosphorylation of Rad18 promote recruitment of Polη to stalled RFs? 1.2 Does Cdc7 regulate recovery from checkpoint-induced S-phase arrest by phosphorylating Rad18? 1.3 What are the consequences of failure to phosphorylate Rad18 at Cdc7 target sites? 2. To test the hypothesis that Cdc7-mediated Rad18 phosphorylation ensures selection of the appropriate TLS polymerase in response to UV- or BPDE-induced DNA damage. 2.1 What are the kinetics of Y Pol recruitment to sites of DNA damage after exposure to different environmental genotoxins? 2.2 Does Cdc7 regulate Polκ-mediated TLS of BPDE adducts?